The role and regulation of deep crypt secretory cells in colitis

PROJECT SUMMARY
Deep crypt secretory (DCS) cells are an understudied lineage of secretory cells residing in the colonic crypt
base with unknown roles in colitis. In preliminary data, I show that DCS cells express a class of proteins known
as host defense peptides (HDPs) that can influence key epithelial (e.g. differentiation, barrier integrity) and
immune functions. Despite clear demonstrations of altered colonic secretory cell numbers and HDP levels in
inflammatory bowel disease (IBD), the mechanisms regulating DCS cells and HDPs are poorly understood.
This proposal is designed to identify the mechanisms driving DCS cell differentiation and HDP
production in colitis, and determine the role of these factors in regulating epithelial and immune
functions. Using a mouse model with elevated DCS cell numbers, I am proposing coordinated in vivo and in
vitro approaches to understand the mechanisms underlying DCS cell differentiation and HDP expression in the
colon (Aim 1) and to test how altered DCS cell-derived HDPs affect colonic homeostasis and acute and
chronic colitis severity (Aim 2). This work will be accomplished with new expertise obtained in advanced
transcriptomic studies and epithelial lineage tracing in models of colitis by working with my team of co-mentors
and advisory committee. This work will advance our understanding of the cellular mechanisms that drive
intestinal epithelial remodeling in colitis, and thus may reveal new potential therapeutic targets for IBD and
other intestinal inflammatory disease. The research and career development plan, generated in concert with
my mentors and advisory committee, will provide the training and support necessary to become an
independent investigator at an academic research institution.

Public health relevance
PROJECT NARRATIVE Deep crypt secretory cells are important for maintaining colonic homeostasis and express a class of proteins— host defense peptides—known to be dysregulated in intestinal inflammatory disease. The studies proposed will advance our understanding of the role and regulation of these cells and their secreted factors in colitis, and will lead to new therapeutic targets for human health.